ADMINISTRATION OF SUBCUTANEOUS INSULIN TO PREVENT IDD IN HIGH RISK NONRELATIVES

The purpose of this study is to determine if subcutaneous insulin given to persons at high risk for developing IDD can prevent their progression to clinically overt disease.